The role of NQR in ROS-dependent virulence regulation in Vibrio cholerae

ABSTRACT
The metabolism of pathogenic microorganisms has to be flexible as the efficient replication of pathogenic bacteria in
the host depends on an active adaptation process. Human infection by the bacterial pathogen Vibrio cholerae, requires
multiple adaptation processes that ultimately lead to robust virulence factor production in the small intestine. Although a
link between the metabolic status and virulence factor expression has been described in several pathogens, it has not been
investigated in detail in V. cholerae. Similarly, the role of membrane bioenergetics in bacterial virulence is not well
understood, although most pathogenic organisms extensively utilize membrane respiration for part of their physiology. Our
previous results suggest that changes in membrane bioenergetics affect virulence gene expression in V. cholerae. More
specifically, loss of the main V. cholerae respiration enzyme (NQR) leads to changes in virulence gene transcription. Here,
we propose to perform an investigation into the link between membrane respiration and virulence gene regulation in V.
cholerae, with an emphasis on reactive oxygen species (ROS) and the quinone pool. It has been well documented that
multiple virulence-associated transcription factors sense oxidative stress in V. cholerae via post-translational modifications
such as thiol-switches. We have previously established NQR as a source of both periplasmic as well as cytoplasmic ROS.
Moreover, we recently developed a method to produce varying levels of ROS in V. cholerae by manipulating the expression
level of NQR and in parallel, the level of cytoplasmic ROS in live cells can be monitored using a novel, fluorophore-based
approach. This system enables us to quantitatively correlate ROS levels with the expression of genes encoding for virulence
factors in V. cholerae. Overall, we expect to gain important insights into the metabolic capacity of this organism per se and
its relation to virulence gene expression as an important aspect of pathogenesis. Our rationale for this project is that the
generation of fundamental information concerning V. cholerae metabolism and its link to virulence factor production will
provide potential opportunities for novel treatment strategies for infections.

Public health relevance
NARRATIVE We have formulated a model for how changes in bacterial membrane bioenergetics (likely by sensing reactive oxygen species produced by the respiration-linked sodium pump NQR) might affect virulence factor production in V. cholerae. Results of the proposed research will not only enhance our understanding of the general bioenergetic pathways in V. cholerae, but will form a solid basis for future investigations of the molecular devices maintaining membrane respiration and their relevance in virulence. A more complete understanding of these mechanisms could ultimately lead to novel intervention therapies to treat human infectious diseases.